Genetic Investigation of Covid 19 in Lung Disease

SUMMARY
The COVID-19 pandemic due to the SARS-CoV-2 virus has resulted in millions of deaths worldwide. The majority
of COVID-19 deaths are caused by lung disease characterized by alveolar filling and severe hypoxemia.
Descriptive studies of human patients, animal models and cultured cells have supported numerous pathogenic
mechanisms for COVID-19 lung disease, including direct epithelial cell infection, vascular cell infection and
thrombosis, and acute respiratory distress syndrome. Despite intense investigation, these hypotheses remain
unproven due to a lack of cellular functional evidence for causality. SARS-CoV-2 infection requires viral binding
of the human ACE2 (hACE2) cell surface protein, and wild-type virus cannot bind mouse ACE2. Existing hACE2-
expressing mice either drive disease through non-endogenous transgenes that do not permit conditional analysis
or fail confer severe illness after infection with SARS-CoV-2. Thus, powerful mouse genetic approaches have
not yet been harnessed to test COVID-19 pathogenic mechanisms. To address this gap in knowledge we have
generated new mouse genetic models that (i) express hACE2 from the mouse Ace2 locus at levels sufficient to
confer lethal disease and hypoxia like that observed in human patients, (ii) permit Cre-mediated loss of hACE2
expression to functionally identify cells required to confer COVID-19 disease, and (iii) permit-Cre mediated gain
of hACE2 expression to functionally identify cells sufficient for COVID-19 disease. Our preliminary studies
identify both epithelial cell infection and vascular disease associated with extensive intravascular thrombosis in
the lungs of hACE2 knockin animals. We therefore hypothesize that COVID-19 lung disease arises due to
synergistic infection and/or dysfunction of both lung epithelial and lung vascular cells. To test this central
hypothesis we will (i) use established Cre-expressing transgenes to test the requirement(s) for epithelial and
vascular cell types during COVID-19 lung disease, (ii) use lung slice explants from human and hACE2 knockin
mouse lungs to map the cells infected by SARS-CoV-2 virus, and (iii) compare acute and chronic lung responses
to infection by the influenza and SARS-CoV-2 viruses to identify the pathogenic mechanisms that underlie the
exceptional lethality of COVID-19 lung disease. These studies are expected to yield a functional and integrated
understanding of the events that underlie COVID-19 lung disease and provide a solid scientific foundation for
the development of novel therapeutic approaches.

Public health relevance
NARRATIVE COVID-19 disease has killed over half a million Americans but our present understanding of its pathogenesis remains based on observational studies that have not reached a clear consensus mechanism. To address this gap in knowledge we have engineered mice that become infected by SARS-CoV-2 virus in a manner that faithfully reflects the human disease, including lethal lung disease and hypoxemia, and in which we can prevent or confer infection of specific cell types to define their roles. We will use these new mouse models and infection of human and mouse lung slices to functionally determine the cellular mechanisms that underlie COVID-19 lung disease, an important step in designing new therapies and halting future outbreaks.